Smartphone app-guided inspiratory muscle strength training for lowering systolic blood pressure

PROJECT SUMMARY
High blood pressure (BP), particularly systolic BP (SBP), is the major modifiable risk factor for cardiovascular
diseases (CVD) and related conditions such as chronic kidney disease and cognitive decline/dementia. In fact,
~60% of adults in the United States have above-normal SBP (≥120 mmHg). Above-normal SBP is associated
with vascular endothelial dysfunction, a key antecedent for developing CVD. In addition, rates of BP control
continue to worsen, predicting a new epidemic of disorders driven by above-normal SBP unless innovative
therapies with clinical efficacy for lowering SBP can be adopted by and translated to the public.
High-resistance inspiratory muscle strength training (IMST) is a novel, low-barrier, time-efficient, lifestyle
intervention involving repeated inhalations against resistance with a hand-held device. In a randomized,
double-blind, sham-controlled, parallel group design, pilot study in men and women (n=36) with initial SBP
≥120 mmHg, I showed that IMST (30 breaths/day [~5 min/day] at 75% maximal inspiratory pressure [PIMAX], 6
days/week for 6 weeks) had excellent adherence (94% of prescribed training sessions completed), increased
inspiratory muscle strength (~20% increase in PIMAX), lowered SBP by 9 mmHg, and improved vascular
endothelial function by ~45% compared to low-resistance sham training – thus establishing the clinical efficacy
of high-resistance IMST. However, this trial was performed with frequent researcher supervision and feedback.
Therefore, the next step in the overall translation of IMST for improving public health is to establish a vehicle
for dissemination of IMST by utilizing digital health technologies.
In this R03 application, I propose to pilot-test a smartphone app that independently guides users through an
IMST intervention. I will directly compare the efficacy of 6 weeks (30 breaths/day, 6 days/week, 75% PIMAX) of
at-home, app-guided IMST vs. an established clinic-based, investigator-supervised IMST program. I
hypothesize that at-home IMST with a smartphone app will lower SBP, improve vascular endothelial function,
promote adherence and increase inspiratory muscle strength to a similar extent as clinic-based IMST. I also
will utilize an innovative follow-up period in which adherence to IMST and changes in home SBP are monitored
for an additional 12 months after completing the randomized controlled trial, under free-living conditions, in all
study participants; this will provide invaluable real-world data to inform future trial designs.
Aim 1: To determine changes in home SBP after 6 weeks of at-home or clinic-based IMST in men and women
with above-normal SBP at baseline. Safety and tolerability also will be assessed.
Aim 2: To measure a) adherence; b) the change in PIMAX; and c) the change in vascular endothelial function
after 6 weeks of at-home or clinic-based IMST.
Aim 3: To monitor adherence to IMST and changes in home SBP during a 12-month free-living follow-up
period in which all participants are given unrestricted access to the IMST smartphone app and training device.

Public health relevance
PROJECT NARRATIVE Systolic blood pressure (SBP) above normal, healthy levels (i.e., ≥120 mmHg) is associated with increased risk for cardiovascular diseases. I recently established the clinical efficacy of high-resistance inspiratory muscle strength training (IMST), a novel form of physical training with minimal barriers to adherence, for lowering SBP in a clinical trial with regular clinic-based, researcher-supervised training. This R03 application seeks to leverage the growing field of digital health technologies to pilot test a smartphone app that independently guides users through a high-resistance IMST program, a key step to translate IMST for widespread use and improving public health.